Targeting Non-Neuronal Mechanisms for Spinal Cord Injury Repair

ABSTRACT
Spinal cord injury (SCI) causes devastating neurological deficits and long-term disability due to axon
regeneration failure. Despite recent progress, successful strategies to promote repair and functional recovery
after SCI remain elusive. This may be because multiple intrinsic neuronal and extrinsic non-neuronal
mechanisms must be targeted simultaneously to promote successful axon regeneration. For example, severed
axons need to be stimulated to regrow long distances through a hostile lesion environment and even then,
optimal functional recovery is unlikely unless regenerated axons are remyelinated. Thus, an ideal treatment
would be delivered as a post-injury medication and would affect each phase of repair. Using whole
transcriptome sequencing and bioinformatic analysis followed by gain- and loss-of-function experiments, we
recently discovered that Cacna2d2, the gene encoding the Alpha2delta2 subunit of voltage-gated calcium
channels, functions as a developmental switch that limits axon growth and regeneration in adult sensory
neurons. Alpha2delta2 pharmacological blockade through systemic administration of Gabapentinoids (e.g.,
drugs used clinically to treat various neurological disorders) promotes axon regeneration after SCI in adult
mice. Our preliminary data suggest that giving Gabapentinoids early after SCI promotes functional recovery.
However, the mechanisms of recovery are not known and it is therefore critical to investigate the cellular and
molecular mechanisms underpinning neurological recovery in SCI mice receiving Gabapentinoids. While
neurons are thought to be the site of action for Gabapentinoids, our preliminary data indicate that extrinsic non-
neuronal mechanisms are also affected by Gabapentinoids. Accordingly, experiments in Aim 1 will use mouse
genetics, tissue clearing methods, three-dimensional imaging of the unsectioned spinal cord and chronic in
vivo multiphoton microscopy to identify structural and functional changes in astrocyte scar formation caused by
Gabapentinoids. The primary goal is to determine what changes in astrocyte reactivity permit axon
regeneration into and beyond the lesion site in animals receiving Gabapentinoids. Aim 2 will explore the
mechanisms by which Gabapentinoids release the tips of severed axons, also called dystrophic endballs, from
entrapment at the lesion site, thereby creating favorable conditions for successful axon regeneration. SCI is
also known to cause progressive demyelination in both experimental murine models and humans, leading to
the axonal dysfunction and degeneration that contributes to loss of function. Using a combination of electron
microscopy, immunohistochemical, electrophysiological and imaging techniques, Aim 3 will test whether
Gabapentinoids promote myelin repair after SCI. Given that our treatment strategy can be readily translated
across different species, implementation of Gabapentinoids-based strategies is well positioned to leverage
significant improvement of neurological outcome following SCI.

Public health relevance
PROJECT NARRATIVE Despite recent progress, successful strategies to promote repair and functional recovery after spinal cord injury (SCI) remain elusive. This may be because multiple intrinsic neuronal and extrinsic non-neuronal mechanisms must be targeted simultaneously to promote successful axon regeneration. This study proposes and aims to test the hypothesis that systemic administration of Gabapentinoids (e.g., drugs used clinically to treat various neurological disorders) promotes neurological recovery and SCI repair via modulation of intrinsic neuronal and extrinsic non-neuronal mechanisms.